Adolescent alcohol drinking and GABA signaling

PROJECT SUMMARY
Adolescence marks a period of increased risk taking and exploration. As part of this exploratory behavior,
many individuals initiate alcohol use during adolescence, which can lead to increased risk for alcohol use
disorders later in life. One major site of adolescent maturation in prefrontal cortex are GABAergic inhibitory
neurons, including parvalbumin positive chandelier cells. Chandelier cells synapse directly onto the axon
potential initiating sites of neighboring glutamatergic pyramidal cells. They are therefore uniquely poised to
regulate pyramidal cell spiking. Here, our goal is to understand how the function of these two inhibitory cell
classes are affected by adolescent alcohol consumption, and to determine if manipulations to chloride
transporter function alters drinking behavior. We will use a combination of electrophysiology and 2-photon
imaging to understand how interneuron function is regulated at the cellular level, and viral manipulation of
chloride transporter function paired with behavior to understand how prefrontal inhibitory function regulates
drinking. Results of this study will provide insight into how inhibitory circuits contribute to drinking behavior
and may elucidate potential therapeutic targets to treat alcohol abuse disorders.

Public health relevance
PROJECT NARRATIVE Relevance: This work focuses on how prefrontal GABAergic synapses are affected by alcohol consumption during adolescence. Adolescence is a key developmental time point for prefrontal circuits, and an age of vulnerability for substance abuse onset. Understanding how prefrontal inhibition is regulated during this critical period may lead to new therapeutic approaches for alcohol use disorders that may result in part from disruption of prefrontal cortex circuitry.